PSC Resource Of Genetic Risk, Environment and Synergy Studies (PROGRESS)

DESCRIPTION (provided by applicant): Primary sclerosing cholangitis (PSC) is a progressive liver disease strongly associated with inflammatory bowel disease (IBD). About 75% of PSC patients are diagnosed with IBD, most commonly ulcerative colitis (UC) and conversely, 5-7% of IBD patients develop PSC. Life expectancy of PSC patients is reduced due to lack of medical therapy, advancement to end-stage liver disease and an increased risk of colon cancer and cholangiocarcinoma (CCA). Thus, while rare in the population, PSC is a notable threat to patients with IBD. Like IBD, PSC is thought to arise as the result of interacting genetic and environmental risk factors. Taken further, the IBD-PSC relationship may be one of overlapping risk capable of prompting both liver and gut involvement, with distinct mechanisms further influencing organ specific disease development. Yet, comprehensive studies focused on the dissection of the genetic and environmental risks in PSC, and its relationship with UC, have not been performed. To this end, we created the PSC Resource of Genetic Risk, Environment and Synergy Studies (PROGRESS). This resource currently comprises 618 PSC patients and 779 primary clinic-based controls; the largest of its kind in North America. Moreover, we have established collaborations between PROGRESS and the Norwegian PSC Research Center (NOPSC), UK PSC Consortium (UKPSC) and IBD Genetics Consortium (IBDGC) to share resources in pursuit of our common goals. In this application, we propose to test the hypothesis that genetic variants and/or environmental mediators contribute to PSC susceptibility and its association with UC. To achieve this, we propose three Specific Aims. In Aim 1, we will expand PROGRESS through continued recruitment of PSC patients at Mayo Clinic and seven other participating medical centers across North America. In Aim 2, we will perform 2 genome wide association studies (GWAS) to identify genetic variants for: (a) susceptibility to PSC- discovery study: 2000 PSC patients and 5000 controls; replication study: 1900 PSC patients and 3000 controls; and, (b) susceptibility to PSC in UC- discovery study: 1400 PSC patients with UC and 1000 UC patients without PSC; replication group: 1330 PSC patients with UC and 1000 UC patients without PSC. In Aim 3, we will determine environmental risk factors for PSC using validated, self-administered questionnaires collected from PROGRESS participants (1000 PSC patients and 1000 controls). This study will begin to identify the genetic variants and environmental factors associated with PSC and its relationship with UC. These findings will serve as foundation for future risk assessment and disease prevention strategies as well as for basic research studies looking for implicated mechanisms and potentially leading to novel therapies for PSC.

Public health relevance
PUBLIC HEALTH RELEVANCE: The goals of this study are to identify genetic susceptibility to and environmental risks for Primary Sclerosing Cholangitis (PSC) and to embark on dissecting its strong association with inflammatory bowel disease (IBD). To achieve these objectives, we established the PSC Resource Of Genetic Risk, Environment and Synergy Studies (PROGRESS) and formed collaborations with national and international consortia of IBD and PSC. If successfully performed, this study will improve our knowledge of PSC and IBD pathogenesis, which could advance the prognosis and therapy of these disorders. Narrative The goals of this study are to identify genetic susceptibility to and environmental risks for Primary Sclerosing Cholangitis (PSC) and to embark on dissecting its strong association with inflammatory bowel disease (IBD). To achieve these objectives, we established the PSC Resource Of Genetic Risk, Environment and Synergy Studies (PROGRESS) and formed collaborations with national and international consortia of IBD and PSC. If successfully performed, this study will improve our knowledge of PSC and IBD pathogenesis, which could advance the prognosis and therapy of these disorders. __SpecificAimsTextDelimiter__ 2. SPECIFIC AIMS To date, the etiology and pathogenesis of Primary Sclerosing Cholangitis (PSC), a chronic cholestatic liver disease, remain elusive despite a strong association with Inflammatory Bowel Disease (IBD), primarily Ulcerative Colitis (UC). The lack of progress is due to the complex nature of PSC, the result of interaction between genetic and environmental risks (1). Establishment of informative models remains unsuccessful and the rarity of PSC has precluded traditional genetic analyses, hampering efforts to identify the associated genetic variants. As a result, there remains no treatment for PSC short of orthotopic liver transplantation (OLT). To this end, in 2005 we established the PSC Resource of Genetic Risk, Environment and Synergy Studies (PROGRESS) a unique and innovative national registry and biorepository aimed at elucidating the genetic and environmental contributors to PSC. Moreover, we have formed resource sharing collaborations with the Norwegian PSC Research Center (NOPSC), UK PSC Consortium (UKPSC) and IBD Genetics Consortium (IBDGC). Our common goals are to generate novel PSC models, discover new treatments and improve outcomes for PSC patients; an effort that is likely to contribute to the understanding of IBD and UC as well. Genome-wide association studies (GWAS) provide unbiased information regarding the genetic basis of complex human disorders (2). While this approach has been successfully utilized in the identification of unsuspected genetic contributors to several diseases, it has not yet been applied to PSC in the US. GWAS would be an important benefit not only to patients with PSC, but also those suffering with UC, whose PSC risk is greatly increased (3). Furthermore, the evidence for a genetic component in PSC is strong (4), though prior "candidate gene" approaches have not been very successful in uncovering robust PSC associations (5). The environmental component of PSC risk is also likely to be strong although possibly quite esoteric as no significant associations except for a protective effect of cigarette smoking (6) have been reported. However, no large epidemiological study of environmental risks for PSC has been performed to date. Such a study may identify novel factors contributing to PSC development, which would provide important insight into this poorly understood disease; and at minimum, documentation of patient exposure history will provide a basis for future studies of interactions between genes and environment that likely underlie this disease. In this proposal we will test the hypotheses that identifiable genomic variants and/or environmental mediators contribute to PSC susceptibility and its association with UC. To accomplish this, we will expand and utilize the considerable resources collected by PROGRESS, in pursuit of our Specific Aims: Aim 1: To expand PROGRESS, an innovative resource for the study of PSC, by: (a) Continuing recruitment of Mayo Clinic patients. (b) Initiating referral of patients to PROGRESS by our external collaborators. (c) Fostering existing relationships with international PSC and IBD study groups. Aim 2: To identify genetic contributors to PSC and its relationship with UC by performing 2 GWAS: (a) GWAS 1: Susceptibility to PSC Discovery - 2000 PSC patients and 5000 "normal" unaffected controls (Patients: New genome-wide assessment of 1285 North American patients and existing genotypes from 715 NOPSC patients) (Controls: Existing genotypes from 3000 Mayo Clinic controls and 2000 NOPSC controls) Replication - 1900 PSC patients and 3000 "normal" unaffected controls (Patients: 1500 DNAs from the UKPSC and 400 additional PROGRESS DNAs) (Controls: 2000 DNAs from the UKPSC and 1000 PROGRESS DNAs) (b) GWAS 2: Susceptibility to PSC in UC Discovery - 1400 PSC patients with UC and 1000 UC patients without PSC (PSC patients with UC: Genotypes of 1400 PSC patients with coexisting UC obtained in Aim 2a) (UC patients without PSC: Existing genotypes provided by the IBDGC) Replication - 1330 PSC patients with UC and 1000 UC patients without PSC (PSC patients with UC: 1050 DNAs from UKPSC and 280 additional PROGRESS DNAs) (UC patients without PSC: 1000 additional DNAs provided by the IBDGC) Aim 3: To determine environmental risk factors for PSC by performing a case:control study of 1000 PSC patients and 1000 unaffected controls, utilizing the self-administered questionnaire data collected by PROGRESS. Discovery of genetic variants and environmental factors that influence predisposition to PSC or its association with UC will provide crucial insight into the mechanisms underlying the pathogenesis of these diseases. Such knowledge will have impact by potentially revealing targets for intervention with medical therapy, or enabling predictive algorithms to distinguish the most susceptible patients for more rigorous medical surveillance.